FY19 TRIAL EXECUTION OPTION ITEM #2 - KENNY-PHASE I SINGLE ASCENDING DOSE STUDY-BPN-19302 (AZD4041) PROTOCOL DEVELOPMENT AND FINALIZATION AND DATABASE BUILD AND BIOANALYTICAL METHODS DEVELOPMENT FOR C

PHASE I CLINICAL TRIALS FOR DEVELOPMENT OF NEUROTHERAPEUTICS